Howard University Research Center for Minority Health and Health Disparities

There are mounƟng evidence showing children exposed to HIV but uninfected (HEU) during
pregnancy as the pregnant mother is on chronic cART present with higher cardiovascular risk at
birth and beyond. In order to miƟgate these risks, there is an urgent need to understand the
effects of the daily intake of the recommended HIV treatment, combined anƟretroviral therapy
(cART), on the newborn during pregnancy. It is important to isolate the cardiac side effects of
the cART in HEU from any residual maternal viral load effects. Therefore, we will study the
effects the components of the cART given to non-infected pregnant rodent model on the HEU.
Furthermore, an assessment of the breastieeding potenƟal compounding effect will be
performed on breastied rodents. This study is of high relevance to the communiƟes with high
HIV risk and cardiovascular diseases, such as in underserved populaƟon afflicted with health
dispariƟes. Understanding the cause can help future studies to alleviate the symptoms.

Public health relevance
Narrative The combination antiviral therapy (cART) for people living with HIV has been transformative by effectively reducing the viral load and enhancing life expectancy. Thus, on one hand it has significantly reduced the transmission and therefore the global spread of the virus. On the other hand, it has changed the lifestyle of HIV-infected person from a devastating dire outcome into a manageable chronic illness. As such, mother-to-child transmission during pregnancy has been significantly reduced due to the effectiveness of the cART and Caesarean deliveries. Nonetheless, there is a chronic exposure to residual HIV and to cART drugs in-utero during pregnancy and during breastfeeding. The latter has been discouraged but compliance is questionable due to economical factors, especially in underserved minority populations, as well as cultural and social influences on the benefit of breast milk. These HIV-Exposed but Uninfected (HEU) children have been clinically shown to be at a higher risk of developing cardiovascular anatomical and functional abnormalities. This is quite alarming, requiring immediate and extensive medical care that may or may not lead to total recovery. In that case, the life quality and expectancy of the child is hampered. Thus, it is exceedingly crucial to investigate such pervasive and significant side effects of the most relevant and recommended cART during pregnancy and breastfeeding periods independently from any putative viral effect. The more prevalent and recommended cART is either Biktavry or Odefsey. In this initial proposal, we will use the components of these 2 drugs either individually or combined during pregnancy and breastfeeding periods to study their individual and combined effects on the heart function and related underlying mechanisms in the newborn and after breastfeeding period. We will directly assess the effects of relevant cART drugs on the hearts from these 2 groups in rodent models by measuring their heart cell function and cellular mechanisms. Data from this initial feasibility proposal will lead the way for more in-depth investigation of any putative mechanism leading to the observed cardiac defects and dysfunctions in HEU.